Walk this Way: Physical Activity and Walking Biomechanics Lead to Early Knee OA Symptoms and Ultrasound-Detected Structural Pathology after ACL Reconstruction

PROJECT SUMMARY
About 250,000 anterior cruciate ligament (ACL) injuries occur annually in the United States and are primarily
treated with a surgical reconstruction (ACLR). However, for at least 1 in 3 young adults with an ACLR, the injury
and surgery are pivotal life events that lead to chronic pain, diminished long-term quality of life, and an increased
risk for osteoarthritis (OA). The 1st year post-ACLR is critical to a patient’s long-term outcomes as there is
evidence that levels of pain and quality of life experienced at 1 year post-ACLR will remain unchanged for up to
10 years. Additionally, at 1 year post-ACLR, ~33% of young adults present with knee structural pathologies.
Unfortunately, there are no evidence-based strategies to identify people during the 1st year post-ACLR who are
at risk for chronic symptoms or structural pathology. Hence, we cannot identify susceptible populations and lack
critical insights into which modifiable risk factors could decrease their risk and prevent lifelong disability.
Potentially modifiable risk factors that are common throughout the 1st year post-ACLR are alterations in walking
biomechanics and insufficient levels of physical activity. Since poor symptoms and pre-radiographic structural
pathology are risk factors for the development of knee OA, understanding modifiable risk factors that relate to
poor symptomatic and structural outcomes during the 1st year post-ACLR is needed for future studies to identify
therapies that prevent OA. The objective of this study is to determine how longitudinal changes in PA and walking
biomechanics assessed at 3, 6, 9, and 12 months post-ACLR relate to poor symptomatic or structural outcomes
during the 1st year post-ACLR. This will be the first study that applies the following outcomes to young adults at
multiple visits during the 1st year post-ACLR: 1) classification criteria for early OA symptoms, 2) clinically
accessible whole-knee ultrasound scoring system to detect multiple structural pathologies. PA will be assessed
with research-grade accelerometers to quantify steps per day and weekly minutes of moderate to vigorous PA
during a 7-day period following each study visit. Walking biomechanics will be assessed in a motion capture
laboratory to quantify vertical ground reaction force and internal knee adduction moment. My central hypothesis
is that participants with a moderate change in PA and walking biomechanics post-ACLR will be less likely to
have poor symptomatic and structural outcomes during the 1st year when compared to people with a rapid
increase or no change in PA and walking biomechanics. The expected outcome of this work is to identify: 1) at-
risk patients post-ACLR who are the ideal participants for clinical trials aimed at preventing poor symptomatic
and structural outcomes, and 2) when PA or walking biomechanics need to be targeted during the 1st year post-
ACLR. This proposal will also provide the PI with the training and mentoring to develop a novel skill set in whole-
knee ultrasound imaging, device-based PA monitoring, longitudinal data analyses, and clinical trial design. This
training and mentoring will directly lead to an R34 clinical trial planning grant to develop a clinical trial using gait
retraining or PA promotion to prevent poor symptomatic or structural outcomes in high-risk patients post-ACLR.

Public health relevance
PROJECT NARRATIVE For at least 1 in 3 young adults with an anterior cruciate ligament reconstruction, the injury and surgery are pivotal life events that lead to chronic pain, diminished long-term quality of life, and an increased risk for osteoarthritis. This study will determine how longitudinal changes in physical activity and walking biomechanics throughout the first year after surgery relate to poor symptomatic or osteoarthritis-related structural outcomes over the same period. This study is significant because it will provide foundational evidence for which patients and which visits to target with existing evidence-based interventions to mitigate the risk of poor outcomes following anterior cruciate ligament reconstruction.